Studying Mitochondrial Dynamics and Energetics During Cardiac Reprogramming

Studying Mitochondrial Dynamics and Energetics During Cardiac Reprogramming
Abstract: Direct reprogramming of cardiac fibroblasts (CFs) to induced cardiomyocytes (iCMs) shows promise
for the treatment of cardiac injury, such as a myocardial infarction (MI). Barriers to clinical application include low
reprogramming efficiency and relative immaturity of iCMs. A metabolic shift from glycolysis to mitochondrial
respiration is required to transdifferentiate CFs to mature iCMs, but this aspect of cardiac reprogramming remains
understudied. In preliminary experiments, mitochondria in native CMs showed higher fusion activity, more
organizational complexity and higher trans-membrane potential than native CFs. By day 15 of standard cardiac
reprogramming, only some of these changes are observable in reprogrammed cells. Knockdown of the
mitochondrial fission regulator Mtfr1l led to improved reprogramming efficiency and iCM maturation. I therefore
propose to characterize a time course of mitochondrial structural and functional changes during cardiac
reprogramming. Additionally, I will investigate the molecular mechanisms of Mtfr1l as a barrier to cardiac
reprogramming and evaluate other mitochondrial perturbations for impact on reprogramming efficiency and iCM
maturation. This work will offer insights into the mitochondrial regulation of cardiac reprogramming and how
mitochondria can be harnessed to improve reprogramming strategies. These insights will bring us closer to
clinical translation of these strategies to benefit patients after MI.

Public health relevance
Mitochondria are crucial to the function of mature cardiomyocytes, but their structural and energetic phenotypes remain under-studied in direct cardiac reprogramming. I propose to characterize mitochondria as cardiac fibroblasts are converted to induced cardiomyocyte-like cells in order to better understand reprogramming mechanisms. I will also investigate whether inducing mitochondria to look and behave more like cardiomyocyte mitochondria can improve reprogramming strategies.